Mindfulness-Based Addiction Treatment Delivered Through Mobile Technology for Low-Income Smokers

Project Summary/Abstract
Adults with low socioeconomic status (SES) experience greater nicotine dependence, are less likely to quit
smoking, and experience profound tobacco-related health disparities. There is an urgent need to improve upon
evidence-based nicotine dependence treatments that are tailored for low-SES smokers. Mindfulness training
increases rates of smoking abstinence and lapse recovery, but in-person mindfulness treatment is not easily
accessible to low-SES smokers. Mobile health technology (mHealth) is an accessible, cost-effective modality
for offering vital 24/7 smoking cessation support. We developed a text messaging program (iQuit Mindfully 1.0)
that provides personalized, interactive mHealth messages to encourage low-SES smokers to use mindfulness
and other smoking cessation techniques in the moments when they need them most. This program was
designed based on iterative feedback from low-SES smokers, and serves as an adjunct to in-person
mindfulness training. Our pilot work demonstrates that iQuit Mindfully 1.0 is feasible, acceptable, and perhaps
most effective for low-SES smokers (i.e., 23.1% of participants living in poverty who received iQuit Mindfully
achieved abstinence at end of treatment and 1-month follow-up, while none of those living in poverty quit in the
in-person-only treatment). However, accessibility would be immensely improved by fully delivering the program
through mHealth. This proposal aims to develop, refine and evaluate feasibility of iQuit Mindfully 2.0 (i.e., iQuit
Mindfully that is fully delivered through an mHealth app to increase accessibility for low-SES smokers). Aims
are: 1) Develop iQuit Mindfully 2.0 using an existing mHealth app platform to deliver mindfulness-based
smoking cessation treatment that is specifically designed for low-SES smokers; 2) Refine iQuit Mindfully 2.0
based on usability testing with low-SES smokers; and 3) Evaluate the feasibility and acceptability of iQuit
Mindfully 2.0. The app will be refined after 2 weeks of preliminary testing with 20 low-SES smokers. Then, 60
low-SES smokers will be randomly assigned to iQuit Mindfully 2.0 (n=30) or the NCI QuitGuide app (n=30) in a
feasibility trial. Participants will complete questionnaire measures and biochemical confirmation of smoking
behavior at baseline, 8, and 12 weeks; weekly assessments of hypothesized psychosocial mechanisms; and
individual in-depth interviews at 12 weeks. The expected products of this feasibility study are: 1) engagement
with the app and follow-up rates; 2) participant ratings and suggestions for further improvement; and 3)
documented trends over time by condition in smoking status and hypothesized psychosocial mechanisms.
Pending feasibility, this study would provide the groundwork for rapid launch of a full-scale randomized clinical
trial to examine efficacy. If efficacious, the iQuit Mindfully app could provide more cost-effective, accessible
smoking cessation treatment (e.g., offered at no cost through federally qualified health centers, substance
abuse/mental health treatment/community centers, etc.) to target health disparities among low-SES smokers.

Public health relevance
Project Narrative Adults with low socioeconomic status (SES) experience greater nicotine dependence, are less likely to quit smoking, and experience profound tobacco-related health disparities. Mindfulness training increases rates of smoking abstinence and lapse recovery, but in-person mindfulness treatment is not easily accessible to low- SES smokers. This proposal aims to develop, refine and evaluate feasibility of a mindfulness-based mHealth smoking cessation program that is specifically designed for low-SES smokers.